In-depth and label-free proteome profiling of hundreds of single cells per day

PROJECT SUMMARY
Cancer tissues exhibit a high degree of phenotypic heterogeneity and plasticity, with cancerous tissues
comprising many different subpopulations of cells in various states. Quantifying this heterogeneity at the single-
cell level and with molecular depth across large numbers of cells provides information that cannot be obtained
from bulk studies and that will ultimately lead to improved diagnostics and more effective treatments. While
single-cell sequencing approaches are having a significant impact on cancer research, proteins mediate the bulk
of cellular function and are the targets of most therapeutics. Given that a compelling body of literature has shown
that the correlation between RNA and protein abundance is at best poor to moderate, there is an urgent need to
develop new technologies for large-scale unbiased direct proteome profiling at the single-cell level. To fill this
gap, mass spectrometry (MS)-based profiling of protein expression in single cells has very recently become a
reality due to more efficient sample processing workflows, novel experimental designs and improved instrument
sensitivity. Label-free MS-based proteomics can currently quantify up to 1500 protein groups per cell across >4
orders of magnitude of dynamic range, but throughput has been limited to ~24 samples per day. This low
throughput is inadequate to perform the large-scale statistically powered studies required to characterize
heterogeneity in cancer cell populations. To increase measurement throughput, multiplexed workflows have
been developed based on isobaric tandem mass tags (TMTs) that enable >10 single cells to be measured in an
LC-MS analysis, but these suffer from a number of significant drawbacks including isotopic contamination,
degraded quantitative accuracy when employing a carrier channel, precursor coisolation with concomitant ratio
compression, chemical noise resulting from cross-reactivities of TMT reagents with contaminants, etc. The
overall objective is to develop a platform that exceeds the throughput of current TMT-based workflows while
preserving the depth of coverage and dynamic range of label-free workflows. We hypothesize that a robust
multicolumn ultra-high-performance nanoLC system with a 5-minute peptide elution window and a 100% duty
cycle, combined with novel MS1-level protein identification and quantification, will enable label-free profiling of
>2000 protein groups per cell at a throughput of up to 288 samples per day, thus providing a providing a capability
for direct, in-depth and large-scale protein quantification that is analogous to single-cell RNA-seq. Studies in Aim
1 will focus on developing high-peak-capacity fast nanoLC separations, as well as a novel sorbent-coated
sample-loop providing desalting and debris removal for robust long-term operation. In Aim 2 we will develop a
4-column LC platform based on these rapid separations and a primarily MS1-based acquisition workflow to
increate duty cycle to 100% and maximize coverage in these rapid analyses. We will apply this technology to
CD138+ single cells isolated from multiple myeloma patients to predict response to immunomodulatory imide
drugs (IMiDs). This project will establish an innovative measurement capability for individualizing cancer therapy.

Public health relevance
PROJECT NARRATIVE There are substantial gaps in our understanding of the role of the tumor microenvironment, the interaction of tumor cell types and their specific responses to cancer therapies. Mass spectrometry-based proteomics enables deep molecular profiling of protein expression that is invaluable for cancer research, diagnosis and therapy evaluation, but it has lacked the sensitivity and throughput to extend these measurements to the single-cell level for large-scale experiments. We will develop a novel platform for in-depth single-cell profiling that combines nanodroplet sample preparation with ultrahigh-performance and multiplexed liquid chromatography-mass spectrometry with a measurement throughput of hundreds of cells per day, which will greatly accelerate cancer research.